Core C-Computational Core

Core C (Computational Core) - Abstract/Summary
Over the past years, the Computational Core has successfully completed multiple large-scale bioinformatics
software development and data generation/analysis projects and built an extensible computational infrastructure
to accommodate various computational needs. The experience acquired, the software base built, and the
infrastructure developed can be leveraged to provide effective and high-quality computational support to all P01
Project teams.
Aim 1 will build an integration/analysis hub to gather public data for the prosecution of in silico studies that are
complementary or in addition to those that Project investigators conduct in their respective groups.
Computational Core supports P01 researchers in the common goal of defining and validating
signatures/biomarkers predicting the reliance of PDAC on alternative pathways or regulatory networks
responsible for tumor growth – particularly in the context of facile comparison to external data. In silico external
data validation has the advantage of being able to scan the available large data sets to seek for quick answers
that would otherwise require commitment of both time and money to accomplish.
Aim 2 focuses on high-quality cancer genomic data analysis. We will provide support to P01 investigators in
statistical analysis on genomic and transcriptomic data to identify differentially expressed genes between cell
populations, genomic groups, disease subtypes, or treatment conditions for biomarker discovery. To better
support the increasing need of tumor microenvironment (TME) research, we implemented advanced analytic
approaches on bulk and single-cell RNA data for biomarker discovery, immuno-clustering, and cancer driving
feature identification. Combining insights from single-cell analysis and bulk sequencing data will greatly help the
advance of cancer immunotherapy research.
Aim 3 will enable P01 investigators to perform genomic characterization using next generation sequencing
technology by leveraging our existing pipeline. We have built a production level NGS data processing and
analysis pipeline that has been used intensively for internal projects and collaborative research. The automated
pipeline can also be used to support the NGS related efforts of P01 Projects 1, 2 and 3 to maintain high quality
and standards.
In summary, the Computational Core is an experienced team with proven records of analytical innovation in
response to scientific needs. We expect that technologies and analytical approaches relevant to P01 Projects
will continue to evolve rapidly and new opportunities will arise. The Computational Core will keep providing P01
investigators with the needed expertise and infrastructure critical to conducting the proposed research.

Public health relevance
Core C (Computational Core) - Project Narrative In addition to traditional computational and statistical support, the Computational Core provides P01 investigators with the needed expertise and infrastructure critical to conducting the proposed studies and validating the results. We collaborate with P01 Projects from designing the experiments, selecting experimental samples, formulating hypothesis, and validating the experimental results. The ultimate focus of our efforts is to assist in identifying potential targets that can result in new therapies for patient.